A novel platform to enhance single cell interrogation of nervous system development

Project Summary
During development, the vast majority of the peripheral nervous system (PNS) is generated from neural crest
cells that migrate extensively into the embryo and give rise to the sympathetic, parasympathetic, sensory and
enteric nervous systems. Sympathetic nervous system (SNS) function is tightly linked to heart rate, blood
pressure and temperature control. During development the sympathetic ganglia (SG) must move and interact
with axons that project from preganglionic neurons (PGNs) in the ventral spinal cord to wire the circuit between
the central nervous system (CNS) and PNS. Tissue repair or regeneration therapies for birth defective or
damaged neural connections between the CNS and SNS offer a potential therapeutic strategy, however, will
require the molecular signature of PGN and SG cell populations prior to clinical translation. Furthermore, one
clinically significant example of mistakes in SNS development is neuroblastoma cancer in infants. Here, we
explore an innovative strategy of novel spatial transcriptomics approaches, integrated multiplexed RNA/protein
detection and visualization, and computational algorithms to uniquely identify and map molecular markers of the
PGN and SG progenitor cell populations to the tissue architecture of the chick trunk anatomy. If successful, this
novel platform will provide a transformative foundation for basic research of peripheral nervous system birth
defects and repair using stem cell-based therapies, and future studies of neuroblastoma initiation.

Public health relevance
Project Narrative Tissue repair or regeneration therapies for birth defective or damaged neural connections between the central and sympathetic nervous systems offer the potential for significant improvements in patient quality of life. However, identification of molecular markers of spinal cord and peripheral sympathetic neurons represents a major roadblock in the field that must be addressed prior to further basic research and clinical translation of stem cell-based therapies. In this study, we explore an innovative strategy to determine these molecular markers using state-of-the-art spatial gene expression profiling, imaging, and computational tools that together will provide a transformative foundation for basic research of peripheral nervous system birth defects and stem cell-based therapies, and is easily translatable to a variety of model organisms.